LEFT VENTRICULAR REMODELING IN AORTEC INSUFFICIENCY

DESCRIPTION (Verbatim from the application): Introduction. Over the last nine years, our laboratory has helped develop and validate the mathematical modeling capabilities that are necessary to clinically evaluate the function of the heart by assessing the systolic and diastolic stress-strain relationships of the in vivo myocardium. This proposal would extend the application of these clinical tools to the comprehensive evaluation of the pathological left ventricular (LV) remodeling associated with severe aortic valvular insufficiency and the time course, degree, durability and prognostic significance of the reversal of this remodeling that occurs after aortic valve replacement (AVR). The accurate characterization of left ventricular remodeling and its reversal would have direct clinical relevance to a large number of clinically significant disease processes.